Developing CRISPR repeats as a means of phylogenetically profiling metagenomic data

01234!5*678"9%9&&!1&&#+)&6$1'(56#),&&3*"&!"'"1-./!"0!!"1"2*""3$#""&&5!06'/)740"$$$
5%"&3#5#%036/'#!7!40$"+8-=#""#&&"%83>*?"5=%0+/*&7!&"0)%"%%'&&"4,!5"0$&6/+"7&09:;<"!"&5)06&/!&&7#!!0"&&##%#+)&&3"&&##$
!!#&,&!&"'+!506/70"%>"@=&"!&

Public health relevance
Project Narrative Our novel approach to microbiome profiling will increase knowledge about the composition of human-associated microbiomes. In the long term, better knowledge of microbiome composi tion will aid design of diagnostics and therapies to restore normal microbiome equilibrium after dysbiosis.